Dietary Contribution in Cerebellar Ataxia

PROJECT SUMMARY/ ABSTRACT Cerebellar ataxia is a disabling symptom and can have a variety of causes, among which immune-mediated gluten ataxia is one of the most common causes. Gluten ataxia is associated with autoimmunity against transglutaminase 6 (TG6) and some patients with gluten ataxia will respond to gluten-free diet. However, the responses to gluten-free diet in patients with gluten ataxia might be variable and there is no clear understanding how TG6 could play a role in ataxia and/or in response to gluten-free diet. Recently, genetic mutations of TGM6, the gene that encodes TG6 protein, have been identified to cause spinocerebellar ataxia type 35 (SCA35). We recently identified a SCA35 patient with a truncated TGM6 mutation and cerebellar ataxia, and his ataxia improved with gluten-free diet, demonstrating that both genetic and immune- mediated causes can converge at the TG6 biology, which serves as a window to probe the dietary contribution in neurological disorders. In this R03 proposal, we will establish the first mouse model of SCA35 and monitor its responses to gluten-diet in ataxia progression (Specific Aim 1), neurophysiology (Specific Aim 2), and neuropathology (Specific Aim 3). This mouse model will serve as a benchmark for future mechanistic studies to understand gluten biology and cerebellar ataxia.

Public health relevance
PROJECT NARRATIVE This study will explore the dietary contribution in neurological disorders, specifically, dietary gluten in a genetic form of cerebellar ataxia. The proposed studies will set up a research platform to study how gluten in the diet can cause neurodegeneration in the absence of a key enzyme for brain gluten metabolism, leading to imbalance. The knowledge learned from this study will advance our understanding of environmental factors, such as diet, in neurological diseases.